NARCH X Admin Core

PROJECT SUMMARY: The goal of the NARCH X White Mountain Apache Tribe (WMAT)- Johns Hopkins University (JHU) Administrative Core is to coordinate functions across the 4 NARCH projects proposed in this application, including: 1) a Student and Faculty Development project that will integrate academic and field-based research training, and 2) three NARCH research projects to: a) address the growing burden of invasive and life- threatening Staphylococcus aureus and Group A Strep infectious diseases; b) reduce trauma-related risks for substance abuse and suicide among Apache adults, and c) address diabetes risk and protective factors among diabetic parents/caregivers and their adolescent children through a family-based home-visiting intervention. Core administrative functions will include the following: Management and facilitation of the NARCH X Community Advisory Board; Coordination of communication among proposed Student/Faculty and Research components; Oversight of federal reporting and fiscal management responsibilities; Oversight of data safety and monitoring; Oversight of confidentiality protections; Oversight of evaluation and long-term strategic planning; Continuous development of resources and strategies to expand and sustain the training, mentoring and research initiatives; Dissemination of information on NARCH training and research progress to tribal members and leaders; allied agencies addressing tribal health and well-being, and the national and global scientific community

Public health relevance
PROJECT NARRATIVE: The White Mountain Apache-JHU NARCH X will builds on our 35-year partnership addressing tribal health disparities and promoting tribal health autonomy. For NARCH X, Apache students and faculty will receive training in public health, biomedical and behavioral sciences, and develop applied skills through three research studies targeting: emerging infectious diseases; family-based diabetes prevention; and, trauma as a root cause of American Indian mental health disparities.